Computational Image Analysis of Renal Transplant Biopsies to Predict Graft Outcome

Project Summary
Kidney transplantation is the most effective modality for treating end stage kidney disease. It provides superior
quality of life and significantly improves survival over dialysis. However, the demand for kidney transplants has
surpassed the supply of usable organs. Because of this deficit, it is important to improve the outcomes of first-
time transplant recipients through intelligent management, thereby optimizing donor organ allocation and
reducing the need for secondary transplants. In assessing the health of a renal allograft, time is of critical
importance. Being able to precisely predict delayed graft dysfunction and modifying treatment strategies
accordingly would be greatly impactful in decreasing chronic rejection events. Existing clinical methods, such as
the Kidney Donor Profile Index, which are based solely on donor demographics and clinical data, are minimally
to moderately predictive of allograft outcomes. Further, current visual, semi-quantitative transplant biopsy scoring
metrics, e.g., Banff, the Maryland Aggregate Pathology Index, and Remuzzi are often not predictive of renal graft
function. Digital image analytical methods that quantify chronic changes in kidney that cannot be done visually,
may offer clues to long-term allograft outcome. Therefore, to address the unmet need of intelligent renal
transplant management, we propose a comprehensive multimodal framework, integrating high-resolution renal
transplant biopsy digital whole-slide images (WSIs), and donor and recipient clinical, demographic, and social
determinants of health data. Using this framework we will combine computer vision and explainable artificial
intelligence (XAI) tools to derive autonomous diagnostic and prognostic models for data-driven, long-term
management of renal allografts. As part of their preliminary work, the investigator team has developed a
computational tool to quantify interstitial fibrosis and tubular atrophy, a chronicity measure in renal transplant
biopsies, and demonstrated that the prediction of estimated glomerular filtration rate at a later time-point after
biopsy using machine learning (ML)-derived image features outperforms those based on routine visual
assessment. This tool will be expanded to incorporate a variety of additional analyses including robust
segmentation of renal compartments in WSIs, leveraging pathologist guided attention to train deep-learning
models, state-of-the-art transformer models for multi-task learning, and XAI to increase interoperability and
accessibility of ML-derived predictions to pathologists. The performance of this pipeline to predict renal allograft
function in a future time-point will be compared with existing methods used in a clinical setting as well as ML-
based methods used for explainable prediction of disease progression in other areas of digital pathology. The
tool will be deployed on a cloud-based platform and the usability by important stakeholders, namely, transplant
renal pathologists, nephrologists, and surgeons will be studied with a goal to eventually include the tool in clinical
workflows. The proposed work will be an invaluable asset for clinicians to take advantage of large collections of
renal transplant biopsy WSIs and inform treatment decisions towards improving renal allograft function.

Public health relevance
Project Narrative It is important to improve the outcome of the first transplants in renal transplant recipients via intelligent management, therefore, reduce the need for second transplants and optimize organ allocation. However, existing clinical methods are either minimally to moderately predictive or often not predictive of future renal transplant graft function. Toward this goal, an objective framework will be developed via quantifying chronic changes in digital high-resolution renal transplant biopsy images, and integrating the resulting quantified scores with patients’ demographic, clinical, and social determinant of health data in a multimodal framework, using a novel explainable artificial intelligence model, to predict future renal transplant allograft function, and making the tool available on the cloud for end-users in an easy-to-use, plug-&-play form that will facilitate collaborative, distributed training, and prediction.